UW Vision Research Core 3 - Animal Models and Eye Organ Culture

CORE 3: ANIMAL MODELS AND EYE ORGAN CULTURE ABSTRACT The goal of the Animal Models and Eye Organ Culture Core is to facilitate the use of animals and eye organ culture to study visual function and visual diseases by qualifying NEI funded researchers. We also assist non- qualifying investigators in generating preliminary data, in support of proposals seeking NIH funding. This is accomplished by providing expertise in complementary animal models across a range of species from rodents to non-human primates (NHPs) and including spontaneous and experimental models of glaucoma, retinal degeneration, ocular vascular disease ocular pharmacology and toxicology and infectious diseases and includes animal handling and anesthesia and, importantly, provision of alternatives to live animal research including eye organ culture. We provide expertise and equipment necessary for the evaluation of visual system structure and function including ERG, multifocal and pattern ERG, VEP, OCT, retinal imaging, tonometry and outflow facility and outflow pathway determination. Because we are one of the only, if not the only, Vision Research Core with an associated regional Primate Center, we are in a unique position to provide access to vision research involving highly translationally relevant NHPs. As a result of this unique expertise, this core has also facilitated vision research by investigators at other institutions and their papers cite this core.